Development of Ultrasound Imaging Phantoms Appropriate for Quantification of Muscle Fascicle Architecture and Mechanical Properties

Because of its low cost and ease of use, there is widespread adoption of ultrasound as an imaging modality for
the musculoskeletal system. For example, traditional, two-dimensional, brightness mode (B-mode) ultrasound is
currently being implemented to quantify muscle morphological adaptations in vivo for a broad and disparate
range of applications. Ultrasound elastography, a newer modality, is increasingly being applied to the
quantification of human muscle tissue mechanical properties. Clinically, musculoskeletal ultrasound has been
promoted as a “first-line imaging modality” for 72 clinical indications. Despite the increasing prevalence of
musculoskeletal ultrasound, there remain critical limitations for its implementation and for interpretation of the
data that results. Clinically, reliability and standardization of training are considered significant obstacles limiting
the quality of clinical ultrasound assessments. Similarly, there is a critical, unmet need to improve validation
methods for the research application of ultrasound imaging. For example, a systematic review of the literature
describing the implementation of B-mode ultrasound for measurement of muscle morphometric parameters
concludes that, while the evidence supports its validity, the evidence is extremely limited and there are
substantial caveats on this conclusion. There are similar limitations relevant to the study of muscle mechanical
properties via ultrasound imaging.
We propose the development of muscle-like phantoms as a first step toward addressing common issues
of reliability, validation, and standardization of training for ultrasound imaging, that connect research and the
clinic. In medical imaging, phantoms are mockups of the tissue of interest, synthesized to mimic critical features,
known geometric organization, or relevant material composition; they are commonly implemented to establish a
type of “gold-standard” performance measure. There are no commercially available phantoms that are applicable
to establish how accurately and reliably either muscle structure or mechanical properties can be quantified via
ultrasound. As a result, the true utility of these widely adopted imaging methods is not being achieved.
This application describes a preclinical study, focused on prototype device development. The long-term
goal for this work is to develop a range of muscle-like phantoms that will enable the study of different muscle
architectures and include physiologically relevant material properties. In this two-year SPiRE funding period, we
will (1) develop materials that mimic the mechanical properties of human muscle and are suitable for ultrasound
imaging, and (2) use these materials to 3D print muscle-like phantoms. We will evaluate the phantoms we
produce relative to how well they replicate structural and material properties of muscles commonly assessed
with ultrasound imaging. The first aim of this study is to develop printable hydrogels that mimic the passive and
active mechanical properties of muscle. The deliverables of this aim include: (i) quantification of the range of
Young’s moduli achievable via 3D printing of hydrogels using a novel third generation stereolithography method,
(ii) demonstration that these materials are suitable for shear wave imaging, (iii) characterization of the maximum
stresses the resulting materials can sustain, and (iv) identification of the formulations that best replicate the
desired properties of skeletal muscle. The second aim will create phantoms that enable the study of muscle
architecture and mechanics with ultrasound. Using the range of materials developed in Aim 1, we will print
artificial muscles that replicate the range of sizes, shapes, and mechanical properties present in the adult human
arm. Phantoms will be evaluated on the ability to distinguish individual fascicles using B-mode ultrasound
imaging, to sustain loads comparable to human muscle, and to have load-dependent material properties
spanning the range reported for muscle. Ultimately, the work proposed here will characterize the potential with
which 3D printing can address the need for muscle-like imaging phantoms, setting the stage for both a future
Merit Review in this area and an assessment of the viability of such a product for commercial translation.

Public health relevance
Veterans tend to report more musculoskeletal disorders that limit their daily activities than non-veterans, and they report these issues at younger ages. Medical imaging methods, like ultrasound, were developed so that clinicians can view internal body structures and make more effective diagnoses to help heal internal injuries and treat diseases. Scientists and researchers use these same imaging methods to understand how human organs and tissues work in the body, and to determine how their function is different after injury, disease, and treatment. This type of research often leads to the development of new technologies and treatments. We propose to develop imaging phantoms for ultrasound studies of muscles. An imaging phantom is a mockup of the tissue of interest; it provides a system for which the “true” values of interest are pre-defined and known, so that errors associated with imaging the unknown values in the body can be understood. Improving methods used to study muscle function in healthy persons and in persons with musculoskeletal disorders is of direct benefit to veterans.